Development of broadly neutralizing human monoclonal antibodies against henipaviruses

PROJECT SUMMARY
Henipaviruses (HNVs), including Hendra (HeV) and Nipah (NiV) viruses, are highly pathogenic agents
causing severe respiratory and neurological diseases in humans and animals. With case fatality rates ranging
from 40% to >75%, and classification as biosafety level 4 (BSL-4) pathogens, these viruses pose a significant
public health concern. Current vaccine and monoclonal antibody (mAb) candidates are targeted against closely
related NiV and HeV. While promising, these narrowly focused approaches are insufficiently broad in their
effectiveness, rendering them inadequate against increasingly diverse HNV clades. This project aims to
overcome this critical gap by developing human broadly neutralizing antibodies (bnAbs) against HNV fusion (F)
and receptor-binding glycoproteins (RBP/G).
Our primary objective is to overcome current limitations by developing bnAbs effective against a wide
range of HNVs, with a secondary objective of assessing the utility of the eliciting immunogens in future vaccine
development. Our approach accounts for the existing diversity among HNVs, targeting not only NiV and HeV but
also Ghana virus (GhV) and Cedar virus (CedV) as representatives of the extant diversity amongst bona fide
henipaviruses. Informed by structure-function data, we will design novel immunogens to elicit broadly neutralizing
antibodies (bnAbs) to HNV F and G proteins. By immunizing Harbour H2L2 mice transgenic for human
immunoglobulin VH-VK genes, we overcome limitations posed by the rarity of convalescent patient samples,
which has commonly been used to derived human mAbs against infectious agents. Our initial characterization
of potent bnAbs derived from immunized Harbour H2L2 mice provide a strong premise for this project. Our
driving hypothesis is that rationally designed immunogens can induce bn Abs, and that these bnAbs can be
developed as prophylactic or therapeutic agents against a broad spectrum of HNVs. We will (1) comprehensively
characterize extant bnAbs already generated from Harbour H2L2 mice, (2) design and engineer immunogens
expected to enhance the immunogenicity of conserved epitopes on F and G proteins, (3) assess the protective
efficacy of developed bnAb candidates in animal models, and (4) develop optimized mAb cocktails for broad-
spectrum HNV therapy. This project is poised to make significant advancements in the development of bnAbs
as countermeasures against the wide array of HNVs. It offers a developmental pipeline that could greatly
enhance our approach to managing these highly pathogenic viruses. The outcomes will not only contribute to
the immediate need for effective therapies but will also have broader implications for the field of antiviral
countermeasures.

Public health relevance
PROJECT NARRATIVE Henipaviruses (HNVs), such as Nipah and Hendra viruses, pose a serious global public health threat due to their high case fatality rates and potential to cause pandemics. Our research aims to develop mAb candidates that can provide broad protection against a wide range of HNVs. In the long term, this work could help enhance global health by reducing illness and disability from HNV infections, contribute to pandemic preparedness, and provide essential insights into the nature and behavior of these highly pathogenic viruses.